HIV-1 Gag Precursor Protein Interactions

Despite great advances in AIDS diagnosis and treatment, the continuing AIDS epidemic demands
continuing efforts to understand all aspects of HIV replication and to develop new methods for its inhibition.
In pursuit of these goals, we have sought to define the activities and interactions of the HIV-1 structural
(Gag) proteins, with a specific focus on the N-terminal matrix (MA) domain. The Gag proteins initially are
synthesized as precursor Gag (PrGag) proteins that are myristoylated at the N-terminus of MA, and MA
domains target PrGag delivery to plasma membrane (PM) virus assembly sites virtue of preferential binding
to the signaling phospholipid phosphatidylinositol-4,5-bisphosphate (PI[4,5]P2). Evidence also indicates that
MA-RNA binding helps chaperone PrGag proteins to assembly sites, and that virus membranes are
enriched for lipid raft constituents such as cholesterol, sphingomyelin, and ceramide. In addition to its
trafficking role, MA has been shown to influence the incorporation of wild type (WT) HIV-1 envelope (Env)
glycoprotein trimers into virus particles. Previous investigations have shown that HIV-1 Env proteins that
carry cytoplasmic tail deletions (CT) in their transmembrane (TM; gp41) domains can be incorporated into
virions in a fashion that is cell type-dependent, but MA-independent. In contrast, MA mutations that impair
WT Env incorporation into virions have been identified. Moreover, other MA mutations have been shown to
suppress Env incorporation defects imposed either by MA mutations, or Env CT mutations. Such
observations imply that there could be direct MA-CT interactions, but proof has been lacking. During the
past funding period, we have made significant progress in understanding how MA and Env proteins interact.
We have shown that MA directly binds to Env CTs, and that binding depends on MA trimerization. We have
demonstrated that C-terminal amphipathic helices of HIV-1 Env CTs are involved in MA binding, and that
MA-CT binding is blocked by MA-RNA binding. We have discovered lipid composition changes that perturb
WT Env activity, and have obtained novel evidence of CT processing. Using this as a foundation, we
propose the characterization of MA-CT interactions and the roles of these interactions in HIV-1 replication.
In particular, we will define how Env proteins associate with MA trimers and lattices so as to determine how
WT Env proteins become incorporated into virus particles; and we will examine how Gag and Env proteins
collaborate in virus particles to perform their functions. Our results will help clarify how HIV Gag and Env
proteins cooperate, and will foster the development of novel approaches to interfere with HIV-1 replication.

Public health relevance
We propose to characterize how HIV-1 Gag and envelope proteins interact to facilitate the assembly of envelope proteins into virus particles, and to regulate the functions of envelope proteins in virus particles. These investigations will help clarify how HIV Gag and envelope proteins cooperate, and will foster the development of novel approaches to interfere with HIV-1 replication.